Food intake control by leptin signaling in the hippocampus

DESCRIPTION (provided by applicant):This proposal describes a 3-year training program designed to provide the candidate (Dr. Scott E. Kanoski) with the expertise needed to incorporate a range of neuroanatomical, molecular, and other career oriented skills (e.g., mentoring, lab management, grant writing) that will broaden the scope of his obesity-focused research career. The proposed training plan will substantially benefit the candidate's ability to establish and maintain a productive independent behavioral neuroscience laboratory at the University of Southern California (USC) conducting research focused on obesity treatment and prevention. The candidate received a Ph.D. in Aug. 2009 and conducted research as a postdoctoral fellow in the Department of Psychology at the University of Pennsylvania. His position as Assistant Professor of Biology at USC begins January 2013. The Department of Biology at USC has a strong research tradition that will provide an ideal training and research environment for the candidate. The primary mentor, Dr. Alan Watts, Professor of Biology at USC, is a well-established researcher in the field of behavioral neuroscience and an expert in the neuroanatomical and neurochemical systems that control energy balance and metabolism. To facilitate the novel interdisciplinary approaches of the proposed research, the candidate will also be guided by co-mentor, Dr. David McKemy (USC), a prominent neurobiological researcher in the fields of somatosensation and nociception, and by Dr. Harvey Grill (University of Pennsylvania), a renowned expert in the neuroendocrine controls of feeding and energy expenditure. The research in this proposal will examine the novel hypothesis that the adipose cell-derived hormone leptin signals in the ventral hippocampus (VHPC), a brain region that regulates learning and motivational processes, to suppress motivational behaviors related to obtaining rewarding, palatable foods. The experiments described in the proposal use a rat model and integrate state-of-the-art neuroanatomical (immunohistochemistry and neurological tracers), molecular (immunoblot, qPCR), genetic (RNA interference), pharmacological (central delivery of agents), and behavioral techniques (learning and memory paradigms). Building directly on preliminary data presented in this proposal, experiments are designed to: 1) assess whether leptin receptor (LepRb) signaling in the VHPC is physiologically relevant to learned motivated behaviors directed towards food procurement, 2) identify the neural circuits that communicate in concert with the VHPC to reduce food intake via leptin signaling, and 3) identify whether food intake reduction by VHPC leptin involves brain-derived neurotrophic factor (BDNF) signaling. Results will contribute to the development of pharmacological obesity treatment by informing about the neuroendocrine and intracellular/molecular systems that control food intake and food-motivated behavior.

Public health relevance
PUBLIC HEALTH RELEVANCE: Over 2/3 of adults in the USA are overweight or obese and there is currently a shortage of effective drug treatments for the excessive food intake that leads to obesity. Basic science is driving pharmaceutical developments for obesity by identifying specific brain chemical systems that reduce food intake. A novel approach is taken here; we believe that more progress can be made towards obesity treatment and reducing associated health care costs if basic research were to focus on understanding the mechanisms through which the hormone leptin signals in the hippocampus, a brain region that controls cognition and rewarding aspects of feeding, to reduce food intake and body weight. __SpecificAimsTextDelimiter__ 10. Specific Aims The prevalence of obesity in the United States has increased by 75% since the early 1980s4, 5 with current estimated average annual US health care costs attributed to obesity in excess of $140 billion6. Effective anti- obesity drugs are urgently needed as behavior therapy offers limited success and gastrointestinal (GI) bariatric surgery, while effective, has serious adverse consequences7. Our understanding of the CNS control of energy balance has progressed dramatically following the discovery of the adipose tissue-derived hormone leptin. Thus far, analysis of the contribution of leptin to food intake control has centered primarily on its signaling in various hypothalamic (e.g., arcuate nucleus, ventromedial hypothalamus) and caudal brainstem (e.g., nucleus of the solitary tract) nuclei that are historically linked with regulating food intake driven by energy deficit. It is clear, however, that the chronic hyperphagia underlying human obesity is not related to energy deficit, but rather is more likely based on appetitive processes, such as food reward and learned associations with environmental cues for food. Understanding the neural systems and neurochemical signals mediating these types of higher-order, motivational processes and their contribution to food intake control is an imperative step forward if the field is to elucidate the bases of the excessive hyperphagia driving obesity. Recent findings from the candidate show that pharmacological administration of leptin to the ventral subregion of the hippocampus (VHPC), a brain region linked with learning, memory and motivational processes, decreases food intake in rats8. Unknown is whether endogenous leptin receptor (LepRb) signaling in the VHPC is physiologically relevant for learned motivated behaviors related to food procurement. Also unknown are the neuroanatomical pathways and downstream neurochemical mediators related to food intake and learned appetitive control by VHPC LepRb signaling. The proposed experiments address these important questions and take advantage of novel complementary genetic, neuroanatomical, molecular, behavioral, and pharmacological approaches to address the following specific aims: Aim I. To determine the physiological relevance for VHPC LepRb signaling in the control of learned motivated behaviors related to food procurement. Our preliminary data employing virally- mediated RNA interference (RNAi) knockdown of LepRb (LepRbKD) in the VHPC indicate an endogenous role for VHPC LepRb signaling in food intake control. Here we propose to determine the behavioral mechanisms by which endogenous VHPC LepRb signaling controls for food intake by examining motivational learning paradigms (conditioned place preference and operant responding for palatable foods) following RNAi- mediated VHPC LepRbKD. These experiments will directly test the hypothesis that endogenous leptin signaling in the VHPC controls food intake by modulating learned motivated behaviors related to the procurement of food. Aim II. To examine whether anorectic signaling by VHPC LepRb neurons involves direct neuronal communication with nuclei involved in rewarding aspects of feeding (the lateral hypothalamus and nucleus accumbens shell). Aim II employs neuroanatomical [immunohistochemistry (IHC)], pharmacological, and lesion methods to examine the neuroanatomical projection targets of VHPC LepRb signaling and their functional relevance. Neurons in the VHPC monosynaptically project to brain regions that control rewarding aspects of feeding, including the lateral hypothalamus (LH)9 and the nucleus accumbens shell (NAcsh)10. Experiments in this aim will utilize double IHC for monosynaptic retrograde tracers (Fluorogold, Retrobeads) injected into the LH and NAcsh combined with VHPC leptin-induced activation of phosphorylated form of signal transducer and activator of transcription 3 (pSTAT3), a widely used marker of LepRb activation, to examine whether VHPC LepRb-activated neurons monosynaptically project to these nuclei. The functional relevance of these pathways will also be assessed by recording food intake and body weight following a "disconnection" pharmacology paradigm involving unilateral VHPC leptin administration combined with ipsilateral excitotoxic lesions of the LH or NAcsh. Aim III. To assess the role of brain-derived neurotrophic factor (BDNF) signaling in food intake control by ventral hippocampal LepRb activation. Using molecular, pharmacological, and genetic (RNAi) techniques, Aim III examines the hypothesis that VHPC LepRb signaling involves downstream signaling by BDNF, a neurotrophin involved in synaptic growth, learning, and memory. Preliminary data show that ventricular leptin delivery increases BDNF protein expression in the VHPC. Aim III will assess whether blockade of BDNF's receptor (Trk-B-R) [using a novel, selective Trk-B-R anatagonist (ANA-12)11] attenuates the food intake suppression and the CPP reduction produced by VHPC leptin. This aim will also examine VHPC protein expression (via immunoblot and ELISA) for phosphorylated cAMP Response Element-binding protein (CREB; a transcription factor critical for BDNF expression12), BDNF, and phosphorylated TrkB-R following pharmacologically induced activation and chronic RNAi-mediated downregulation of VHPC LepRb signaling.